Administrative Core

PROJECT SUMMARY/ABSTRACT
The Administrative Core will serve all four Component Projects including Core B over the five years of the
renewal Program Project. The overall goals of the Administrative Core are to serve as an integrated unit for the
entire Program Project team to monitor and foster coordination of the scientific interactions across all Projects,
maximizing collaborative interactions with each other, with the subcontract investigators as well as the Internal
and External Advisory boards. This Core will be responsible for careful financial management of the Program
Project, strict adherence to all NYBC and NIH guidelines and research regulations, handle new hiring associated
with staffing the projects and schedule regular meetings of the entire Program Project. Aim 1 will provide
supervision of program finances, administrative and secretarial support, maintenance of authorizations and
adherence to institutional requirements as well as oversight of data reporting and compliance with NIH Data
sharing policy and coordination of the subcontract to Montefiore Medical Center and University of Illinois,
Chicago. Aim 2 will coordinate meetings of the Program Project team, including the Project Leaders, Core
Leaders, all scientific and technical staff at NYBC, and all the members of the subcontract teams with the goal
to facilitate sharing of systems, reagents and findings among all groups within the Program Project. Finally Aim
3 will coordinate meetings of the Internal and External Advisory Boards for the Program Project to ensure periodic
review of the projects/cores, next steps and future directions with the overall advisors.

Public health relevance
The Administrative Core will serve the entire Program Project team to foster coordination of the scientific interactions across all Projects, maximizing collaborative interactions and will be responsible for adherence to institutional requirements, oversight of data reporting and compliance with NIH Data sharing policy, financial management as well as provide administrative and secretarial support of the Program Project.